Clinical, Radiologic and Biochemical Factors Related to Diabetes Development after Acute Pancreatitis

Abstract
Nearly 40% of patients develop diabetes after an initial episode of acute pancreatitis (AP). Various studies have
evaluated risk factors for the development of diabetes but they have shown inconsistent findings, suggesting
methodologic shortcomings. The present proposal consists of three specific aims where we will attempt to
determine the biochemical, radiologic and clinical factors related to the development of diabetes after AP. Aim
1: To identify autoantibodies associated with the progression of type 1 diabetes in patients after AP using a large
human proteome array. Aim 2: To study the role of imaging, more specifically quantitative textural analysis to
predict the development of type 1 diabetes after AP. Aim 3 is to build a machine learning model to predict type
1 diabetes after AP using patient-related risk factors, textural analysis on imaging and autoantibodies involved
in disease progression. Our proposal will help us better understand diabetes after AP. Successful completion
of this study has the potential to improve management for AP.

Public health relevance
Project Narrative Relevance to Public Health Statement Acute pancreatitis is increasing in incidence and can lead to diabetes in some patients. Diabetes is a morbid disease. We plan to study both established and novel risk factors for developing diabetes in patients with acute pancreatitis.